CIVIC: VACCINE MANUFACTURING AND TOXICOLOGY CORE FOR SARS-CoV-2

To provide expertise and state-of-the-art approaches to manufacture, formulate, optimize, and evaluate the safety and toxicity of innovative, cutting-edge vaccine platforms and approaches.